Viral and host predictors of BK polyomavirus associated hemorrhagic cystitis

PROJECT SUMMARY/ABSTRACT
The overall goals of this proposal are to investigate the mechanisms of bladder injury (hemorrhagic cystitis)
associated with BK polyomavirus (BKPyV) infection in children and young adults undergoing bone marrow
transplantation (allogeneic hematopoietic cell transplantation, HSCT). BKPyV-associated hemorrhagic cystitis is
a complication for up to 25% of allogeneic HSCT recipients. Hemorrhagic cystitis leads to patient morbidity from
painful urination, prolonged hospitalizations, increased blood transfusion requirements, and invasive procedures
when urinary obstruction is present. Each episode of hemorrhagic cystitis accounts for 10 additional hospital
days and costs $70,000. In its most severe presentation, hemorrhagic cystitis may be associated with a higher
risk of death. BKPyV replication in the urine can be detected in 80% of HSCT recipients, but not all of these
patients will develop hemorrhagic cystitis. There are no antiviral therapies with proven efficacy against BKPyV
and current treatment strategies for hemorrhagic cystitis are limited to supportive care. A major barrier to
developing and testing novel therapies is our lack of understanding the mechanisms of bladder injury
in patients with BKPyV replication. This also prevents the identification of the patients at highest risk for
bladder injury. The central hypothesis of this proposal is that the risk of hemorrhagic cystitis after HSCT is a
function of both BKPyV subtype and the host response to the virus. To test our hypothesis, we will study two
separate prospective observational cohorts: an existing group of 193 children and young adults who received an
allogeneic HSCT at Cincinnati Children’s Hospital Medical Center or the Children’s Hospital of Philadelphia with
already banked urine samples and an independent validation cohort of 200 children and young adults undergoing
allogeneic HSCT to be enrolled during the award period at these same two centers. The project’s specific aims
are: 1) to test whether the population or within-person BKPyV diversity is different between patients with and
without hemorrhagic cystitis after HSCT and to enroll the validation cohort; and 2) to test whether host cellular
responses or specific gene polymorphisms are different between subjects with and without hemorrhagic cystitis
after HSCT using proteomics and transcriptomics approaches. This study’s results are expected to increase our
understanding of the viral and host mechanisms of bladder injury after HSCT. The data from this application are
critical for identifying the patients at highest risk of hemorrhagic cystitis who would benefit from cellular therapies
and other targeted, future prevention or treatment strategies.

Public health relevance
PROJECT NARRATIVE Hemorrhagic cystitis or bleeding from the bladder occurs in up to 25% of bone marrow transplant recipients and is associated with BK polyomavirus infection, although the mechanisms of bladder injury are not known. The proposed research project will test the hypothesis that the risk of hemorrhagic cystitis in patients with BK polyomavirus replication in the urine is a function of the viral subtype and the host response to the virus. This research will provide the foundation for future clinical trials testing if strategies such as the infusion of exogenous T cells can prevent or treat BK polyomavirus-associated disease and subsequently decrease morbidity and mortality for transplant patients.